Osteoclast-Osteocyte Interaction's in Paget's Disease

Project Summary/Abstract:
Paget’s Disease (PD) is usually diagnosed in patients >50 years of age, and is characterized by focal bone
lesions (PDLs) that progress from an initial lytic to a mixed osteolytic-osteoblastic phase, due to rapid new bone
formation. PD patients rarely develop new PDLs beyond those present at diagnosis. The primary cellular
abnormality in PD resides in the osteoclast (OCL). However, the mechanisms responsible for the highly focal
nature of PDLs, why PD is diagnosed in elderly patients, especially in patients harboring genetic mutations
linked to PD, and the mechanisms driving the exuberant resorption/formation in PD, are unclear. We showed
that OCLs from 70% of PD patients express measles virus nucleocapsid protein (MVNP), and transgenic mice
with MVNP targeted to OCLs (MVNP mice) develop PDLs and the abnormal OCLs characteristic of PD. MVNP-
expressing OCLs and OCLs from PD patients are hyper-responsive to RANKL and express high IL-6 levels,
which induce high levels of IGF1 in OCLs (OCL-IGF1) to promote osteoblast (OB) differentiation in MVNP mice.
Importantly, OCLs from PD patients but not normal donors also express increased IL-6 and IGF1. We confirmed
OCL-IGF1’s role in PD and normal bone remodeling in vivo by generating WT and MVNP mice with targeted
deletion of Igf1 in OCLs. We found that MVNP mice but not MVNP mice lacking OCL-Igf1 developed PDLs.
Thus, high OCL-IGF1 levels in PD may be required to induce PDLs. However, these results do not explain why
PDLs occur in aging patients or animal models and persist locally for long periods. These observations are
most readily explained by stochastic changes in a long-lived bone cell population, most likely osteocytes
(OCys). In this proposal we will test the Hypothesis: that pagetic OCL precursors, which are hyper-responsive
to RANKL, home to specific skeletal sites containing senescent, pre-lesional OCys that produce or induce
locally increased RANKL. As PD-OCLs numbers increase, they hyper-secrete sufficient IL-6 and IGF-1 to
decrease Sost/sclerostin, increase expression of Wnts, block OCy differentiation and act directly on OB to
enhance new bone formation. In preliminary studies, we found that OCys in PD (PD-OCys) express lower
levels of OCy maturation markers, and display markedly reduced dendritic processes. Further, the percentage
of sclerostin+ OCys adjacent to PDLs in MVNP mice was significantly lower compared to MVNP mice without
PDLs or WT mice, and that IGF1 suppressed sclerostin expression in OCys. Importantly, similar morphologic
changes occurred in OCys in bone samples of a PD patient, but not a normal donor. These results suggest
that OCys may be key contributors to the pathogenesis of PD. To further test this hypothesis, we will: Aim 1.
Characterize OCL-IGF1’s effects in PD and PD-OCys, identify the molecular mechanisms involved, and test if
increased OCL-IGF1 is sufficient to induce PDLs and PD-OCys. Aim 2. Determine the role of senescent OCys
in the location, development, progression and persistence of PDLs and PD. We will assess if prolonged
exposure of PD-OCLs to normal OCys, or shorter exposure to OCys in older mice suffices for PDLs to develop.

Public health relevance
Project Narrative: Paget’s Disease (PD) is a common bone disease, characterized by highly localized pagetic bone lesions (PDLs) that result from local increases in bone destruction, followed by rapid formation of bone that is of poor quality. However, the mechanisms responsible for the highly focal nature of PDLs, why PD is diagnosed in elderly patients and why the lesions persist for long periods are unclear. This proposal will determine the role of osteocytes, a type of bone cell that comprises 95% of the bone cells in the adult skeleton and can persist for decades, in the development of PD and PDLs, which is currently is unknown.